Core B: Clinical Core

Clinical Core Abstract
The Clinical Core will: provide the logistical support for Projects 1 and 2, initiate the 5 clinical
sites, monitor recruitment of subjects across the study sites into the remission and active lupus
cohorts (SLE-R and SLE-A) and healthy controls (HC), and ensure that subjects are correctly
classified and meet criteria for their respective cohorts. The Clinical Core will also ensure that
the subset of subjects enrolled in Project 2 meet all additional enrollment criteria for this project.
With the assistance of the Biostatistics and Data Integration Core, the Clinical Core will monitor
the distribution of race and ethnicity in SLE-R to optimize demographic comparability between
SLE-R and SLE-A and HCs. It will track the progress of SLE-R subjects with site notifications of
upcoming visits for Project 1 and 2 assessments and facilitate and coordinate biospecimen
shipments to the Feinstein Institutes of Medical Research. Additionally, the Clinical Core will
monitor protocol compliance, data integrity, and regulatory compliance. Although safety issues
are likely to be few if any in this observational study, the Clinical Core will implement and
maintain the Data Safety Monitoring Plan.